Multifunctional Ionic Liquid Application for Treatment of Peri-implant Diseases

ABSTRACT
Peri-implant (PI) diseases, mucositis and peri-implantitis, eventually affect ~25-50% of dental implants after
placement, resulting in soft tissue and bone destruction. Current treatments target dysbiosis of the oral
microbiome (mature plaque) on the implant surface as the primary etiological factor of PI diseases. Conventional
treatment options include mechanical and/or chemical debridement, laser treatment, ultrasonic scaling, and
implantoplasty. Despite improvements in biofilm removal, decontamination may inadvertently worsen PI disease
prognosis by damaging the implant surface, generating ions/particles that exacerbate the host inflammatory
immune response. Furthermore, these detoxification protocols do not address the chronic inflammatory
environment sustaining PI host tissue destruction. The lack of controlled immunomodulation at the PI diseased
site can hinder re-integration of host tissue with a previously biofilm-contaminated implant surface. Thus, the
ideal PI disease treatment should (i) eliminate infection, (ii) preserve Ti surface condition, and (iii) possess
immunomodulatory activity conducive towards healing at the tissue-implant interface. Previously, our research
group demonstrated the use of dicationic imidazolium-based ionic liquids (IonLs) with amino acid-based anionic
moieties as multifunctional coatings on dental implants. In particular, we showed that IonL functionalized with
phenylalanine (IonL-Phe) formed stable coatings on Ti, imparting host cell compatibility, antimicrobial activity,
anti-corrosive ability, and lubrication in vitro in addition to in vivo biocompatibility and oral osseointegration in a
rat model. During in vivo assessment, IonL-Phe-coated Ti implants also differentially upregulated inflammation
resolution and bone matrix marker genes versus non-coated implants. This observed immunomodulatory activity
motivated evaluation of IonL-Phe application as a multifunctional therapeutic agent for PI disease treatment. To
assess the potential of IonL-Phe in combination with detoxification regimens to promote implant re-integration,
the following aims are proposed. In Aim 1, a standard method for application of IonL-Phe will be determined
based on release kinetic studies and its effect on detoxified Ti surface properties. In Aim 2, an in vitro evaluation
of IonL-Phe application on plasma protein deposition and subsequent effect on mammalian cell growth under
bacterial challenge or multispecies bacterial adhesion on detoxified Ti will be performed. In Aim 3, the in vivo
impact of IonL-Phe application on protein layer formation, host tissue re-integration with Ti implant surface, and
oral microbiome composition will be assessed after induction of PI diseases in a rat model. The proposed study
will address the current clinical gap in treatment of PI diseases by elucidating the ability of IonL to (i) protect the
implant surface during the acute healing phase, (ii) mitigate regrowth of bacterial biofilm, and (iii) actively
modulate the immune response towards soft tissue healing and re-osseointegration. If successful, this project
will enable application of IonL-based treatment modality in combination with current detoxification methods to
target dysbiosis and immune balance during the onset of PI diseases.

Public health relevance
Project Narrative: Peri-implant (PI) diseases, mucositis and peri-implantitis, are triggered by dysbiosis of the oral microbiome, resulting in destructive host inflammatory immune response. Current PI disease treatment protocols are unpredictable and PI disease reoccurs in 42-58% of implants 5 years post treatment. Thus, in this study a multifunctional ionic liquid based dental implant coating technology will be further developed as a clinical treatment modality to target dysbiosis and immune imbalance during the onset of PI diseases.